Development of a model for determining fluid bilayer structure from cryo-EM images of biomembranes.

The ability to accurately measure biomembrane structure is critical for understanding its role in membrane
functionality, but the complexity of the cellular environment makes this an exceedingly difficult task at present.
This study aims to provide proof-of-principle for using cryogenic electron microscopy to quantify key membrane
properties such as thickness and average molecular area, even in heterogeneous samples with multiple types
of membrane domains. The knowledge gained from this project will help open a new window into the nanoscale
architecture of the cell.

Public health relevance
Project Summary In response to a changing environment, living cells can dynamically alter the biophysical properties of their membranes by adjusting their lipid composition. The ability to accurately measure bilayer structure is therefore critical for unraveling membrane structure/function relationships and ultimately lead to a better understanding of biological phenomena and improved therapeutics. While small angle scattering has long been the gold standard technique for this purpose, its application to complex and heterogeneous samples such as cells is severely limited by ensemble averaging. Cryo-EM imaging offers an alternative approach for the determination of nanoscopic structural features that benefits from the ability to visually isolate and analyze specific membranes or membrane domains within heterogeneous samples. However, unlike neutron and X-ray scattering, electron scattering is influenced by the membrane dipole potential and further subjected to microscope focusing optics that are absent from traditional scattering instruments and must be quantitatively accounted for. In Aim 1, we propose to develop an analytic model for fitting the power spectrum of membrane images to accurately recover bilayer structural parameters including membrane thickness and average molecular area. Synthetic ground truth image datasets derived from atomistic simulations of lipid bilayers will provide crucial checks on the precision and accuracy of obtained results. Once the model is validated, we will use it to analyze experimental cryo-EM datasets from fluid bilayers of varying thickness and molecular density, for which independent structural data exist. In Aim 2, we will use the model to determine the structure of coexisting liquid phases in ternary lipid mixtures that are models for lipid rafts. After identifying phase domains with machine learning, we will use image masking to isolate signal from the individual phases and separately recover their structural parameters. If successful, this project will pave the way for a detailed structural assessment of the compositionally distinct membranes of intact cells that has thus far eluded conventional scattering-based approaches.